Cyclic di-AMP-dependent signaling in tickborne relapsing fever Borrelia

PROJECT SUMMARY/ABSTRACT
The vector-borne spirochetes that cause relapsing fever are transmitted to humans by either ticks or human
body lice. Despite identification of the etiological agents of relapsing fever over 100 years ago, very little
information exists regarding their pathogenesis. Although relapsing fever is more common in developing
countries, tickborne relapsing fever (TBRF) occurs in areas of the U.S. where Ixodes and Ornithodoros species of
ticks, the vectors for TBRF spirochetes, are endemic. During their natural enzootic cycle, vector-borne
spirochetes exist in two distinct niches found within the arthropod vector and the vertebrate. It is well
established that Lyme disease spirochetes must undergo significant changes in global gene expression to allow
them to adapt to these two diverse environments. Cyclic dinucleotide second messengers (e.g., c-di-GMP and
c-di-AMP) play key roles during the enzootic cycle of Borrelia burgdorferi, but their regulatory contributions in
TBRF spirochetes have not been investigated. We will test the role of the c-di-AMP signaling pathway in
promoting adaptation of TBRF spirochetes to the different host environments encountered during the bacterial
natural lifecycle. Because the c-di-AMP signaling pathway is found in all pathogenic Borrelia, findings from this
work also has the potential to provide insight into the function of this system in Lyme disease Borrelia. In
Specific Aim 1, we will inactivate individual components c-di-AMP signaling system in the TBRF spirochete,
Borrelia turicatae, and define their roles in messenger molecule production and general spirochetal physiology.
We will also study the regulation of individual pathway components and c-di-AMP synthesis. Specific Aims 2
and 3 will elucidate the impact of the c-di-AMP signaling system on global regulation, pathogenesis, and vector
colonization/transmission. These aims will provide critical knowledge regarding the regulatory networks that
control B. turicatae adaptation during transmission and infection and identify virulence determinants required
by the bacteria for host-pathogen and vector-pathogen interaction(s). Regulators and virulence factors
identified in this project represent potential targets against which future therapeutic interventions and/or
diagnostics for TBRF could be developed. Molecular characterization of the c-di-AMP-dependent signaling
system and c-di-AMP-regulated virulence determinants will be the focus of future R01 grant proposals.

Public health relevance
PROJECT NARRATIVE The vector-borne spirochetes that cause relapsing fever are transmitted to humans by either ticks or human body lice, and although the etiological agents of relapsing fever were identified over 100 years ago, very little information exists regarding the pathogenic strategies employed by these bacteria. We will gain critical knowledge regarding the regulatory networks that control adaptation of tickborne relapsing fever spirochetes during transmission and infection and identify virulence determinants required by the bacteria for host-pathogen and vector-pathogen interactions. Regulators and virulence factors identified in this project represent potential targets against which future therapeutic interventions and/or diagnostics for tickborne relapsing fever could be developed.